Allostatic load, Response to discrimination stress, Discrimination Exposure frequency, and social Network structure and function (ARDEN)

ABSTRACT
The current proposal seeks to rigorously test how interpersonal discrimination contributes to acute and chronic
stress, allostatic load and related health risk among Hispanics and how aspects of social support networks
may mitigate these effects by reducing stress contagion. Our project focuses on discrimination, as immigrant
Hispanics – particularly recent immigrants – often report discrimination at substantially lower frequencies than
US-born Hispanics. This in turn may contribute to immigrant Hispanic’s health advantages, such as 3
additional years life expectancy, relative to US-born Hispanics. The Weathering Hypothesis and theories of
allostasis suggest that the cumulative effects of discrimination exposure and related stress would explain these
health disparities. However, this proposal will be among the first to test mechanisms of how discrimination
stress contributes to allostatic load, with a focus on social and cultural mechanisms; moreover, we will extend
this work beyond the individual to understand how discrimination stress acts on a social network. Research in
White populations has documented how social support protects against the negative health effects of stress,
but little work has examined these effects in Hispanic samples. Moreover, prior research does not account for
how social support may perpetuate stress across a network: that is, when one person experiences stress, their
supportive others will also experience stress. This is particularly relevant for stressors like discrimination, which
impact not only the target but also their social ties. Thus, in order to mitigate the effects of discrimination,
support networks may need to be used in specific ways and have specific qualities. The current study tests
these qualities. First, we will determine the extent to which discrimination stress response and discrimination
exposure frequency combine to predict changes in allostatic load, and in turn predicts risk for multiple chronic
health outcomes that are leading causes of death (e.g., cardiovascular disease). Second, we will determine the
social network qualities that mitigate discrimination stress “spilling over” from one person to another. Finally,
we determine how discrimination stress response transmits across a network to predict changes in the
networks’ allostatic load. To achieve this, we will use sampling designs (respondent-driven sampling; RDS)
and social network analyses that allow us to understand how the connections across people influence health.
We will examine social support; biomarkers of allostatic load, acute and chronic stress, and inflammation; and
daily diary assessments of discrimination frequency. Using novel Bluetooth technology developed by our team
we will also assess how often participants interact with one another and link that data to each participants
reports of discrimination and whether they discussed discrimination with supportive others. The combination of
these measures and network-based approach allows us to conduct novel tests of how social environments
influence health and potentially convey health resilience in the face of discrimination. Additionally, it will inform
how to best arrange social support interventions to limit the negative effects of interpersonal discrimination.

Public health relevance
PROJECT NARRATIVE The proposed research will examine how discrimination stress affects a range of chronic disease outcomes, and how social relationships may buffer these effects to increase resilience in a social system. It will yield new knowledge and ultimately new interventions for how to best utilize social support structures in the context of recurrent discrimination stress with implications for several chronic health concerns that are leading causes of death in the U.S., such as cardiovascular disease.